Geroprotective Precision Medicine Strategies in PWH that Use Alcohol

ABSTRACT
People with HIV (PWH) suffer high rates of geriatric comorbidities and frailty syndromes due, in part, to
unhealthy behaviors including harmful alcohol use. There is a paucity of evidence guiding treatment of geriatric
comorbidity in PWH that use alcohol. This Project addresses the critical need to validate efficacious therapies
for precocious aging in PWH with a significant history of alcohol use. Our group has identified microbiota
characteristics linked to clinical frailty and senescent CD8+ T cells across distinctly different populations with
different health behaviors. However, the specific relationships between the microbiota vary between studies,
suggesting that personalized interventions are essential to prevent the development of clinical frailty. Precision
medicine strategies incorporating host factors, the microbiota, and the exposome hold therapeutic promise. We
have identified changes in the microbiota associated with alcohol use in humans that mediate the prevalence
of senescent T cells in the circulation. In preclinical models, we have identified several alcohol-induced
microbiota characteristics that mediate T cell function. Probiotics and antioxidant foods mitigate alcohol effects
effectively in animal models but results in humans are inconsistent, likely due to inter-individual heterogeneity.
Thus, there is a compelling rationale and necessity to develop personalized probiotic selection strategies as
geroprotective interventions.
The overall objective of this proposal is to identify personalized approaches to overcoming inconsistent
responses to microbiota-targeted geroprotection and then validate the capacity of these precision medicine
strategies to offset mechanisms of biological aging in PWH that consume alcohol. Our approach will test two
Generally Recognized As Safe (GRAS) treatments, a Lactobacillus reuteri probiotic and a blueberry-based
antioxidant mix, and their interactions with well-characterized human hosts to inform machine learning (ML)
enabled predictive algorithms and to identify mechanisms contributing to treatment-specific effects.
Our overarching hypothesis for this project is that an individual’s characteristics predict probiotic and
blueberry supplement capacities to reduce senescent CD8+ T cells in PWH that use alcohol.
The Specific Aims of our proposal are: Specific Aim 1: To derive and validate machine learning predictive
algorithms that guide selection of probiotic and blueberry treatments to maximize the reduction of senescent
CD8+ T cells in PWH that use alcohol. Specific Aim 2: To identify probiotic- and blueberry-specific effects on
mechanisms contributing to senescent CD8+ T cell changes and aging biology characteristics in PWH that use
alcohol. This project will provide [a] proof of concept of precision medicine geroprotective / senoprotective
strategies, [b] mechanistic insights as to the impact of probiotic and antioxidant foods on aging mechanisms,
and [c] a roadmap to optimize other treatments to maintain healthspan in aging PWH that use alcohol.

Public health relevance
NARRATIVE The overall objective of this proposal is to identify individualized probiotic and blueberry treatments that reduce the biological changes in immune cells that occur with aging in people with HIV that use alcohol. We will test these two treatments in a mechanistic clinical trial to test Artificial Intelligence-enabled predictions as to which persons will respond best to which treatment. This project will provide proof of concept of precision medicine geroprotective / senoprotective strategies, and a roadmap to optimize a broader array of generally recognized as safe (GRAS) agents, like probiotics and nutritional supplements, to maintain healthspan in our aging population, particularly for people with HIV that use alcohol.